Role of T-bet B cells in rheumatoid arthritis

Although new treatments have improved outcomes in rheumatoid arthritis (RA), disability remains
high, most patients have ongoing disease activity, and lasting remissions are rare. A major gap
in the field is the elusive identity of pathogenic cells driving persistent inflammation and bone
erosion. Our lab focuses on the identification of pathogenic B cell subsets in RA, which might
drive persistent and aggressive disease. We reported that B cells promote bone erosion by
RANKL/TNF-mediated differentiation of monocytes to osteoclasts (OCs) and TNF/CCL3-
mediated inhibition of osteoblasts (OBs). Importantly, synovial B cells express much higher levels
of these bone pathogenic factors. More recently, we identified a subset of B cells expressing the
classic T cell lineage defining transcription factor T-bet enriched in the RA synovium and
correlating with disease severity and the abundance of SLAMF7 pro-inflammatory monocytes.
We find that synovial T-bet B cells express cytokines influencing OCs/OBs, SLAMF7, and the T-
bet inducible chemokine receptor CXCR3. Remarkably, mouse B cells lacking T-bet did not
activate OCs or inhibit OBs. Based on our results, the central goal of this proposal is to define
how T-bet influences synovial B cell states, mediates B cell-driven bone effects on OCs/OBs, and
coordinates B cell pathogenic functions in RA target tissue, contributing to joint erosion and
synovial inflammation. We hypothesize that T-bet promotes pathogenic B cell functions in the RA
synovium via acquisition of a pro-inflammatory cytokine/chemokine program that orchestrates
CXCR3-dependent B cell migration to the synovium and enhances SLAMF7-dependent
monocyte activation and bone erosion. We will use deeply characterized RA patient cohorts, high-
resolution single cell transcriptomic and spatial analysis of joint target tissue, and novel animal
models to track T bet B cells and selectively and conditionally delete T-bet in B cells of mice with
collagen induced arthritis. The combination of preclinical and translational studies will facilitate
the mechanistic interrogation of T-bet B cell functions in RA via 3 SAs: 1) Determine the
mechanisms by which B cell T-bet promotes RA joint erosion; 2) Assess how T-bet B cells impact
RA synovial monocyte activation; 3) Examine the role of T-bet in B cells during inflammatory-
erosive arthritis in mice. By detailing the functional impact of T-bet B cells, innovative treatments
targeting their activity may be a novel path towards preventing bone erosion and conferring lasting
clinical remissions.

Public health relevance
Project Narrative Despite advances in understanding the immuno-pathogenesis of RA, disability remains high due to persistent inflammation and joint damage from increased osteoclast (OC)-mediated bone erosion and decreased osteoblast (OB)-mediated bone formation. Remissions are rare. We will evaluate how a novel subset of B cells, expressing the transcription factor T-bet, contribute to ongoing disease activity and inhibit bone-forming OBs and activate bone-eroding OCs, thus contributing to inflammation and joint destruction. This research is important because a better understanding of disease pathogenesis will ultimately lead to new therapies and allow patient- tailored treatment strategies.